Pediatric Heart Network Clinical Research Centers - Boston Children's Hospital

The Heart Center (HC) at Boston Children’s Hospital (BCH) has been an enthusiastic and productive Core
Clinical Research Center in the Pediatric Heart Network (PHN) since its inception in 2001. Our volume is large
and, in calendar year 2022, included 840 open-heart operations, 1470 catheterizations, 29,045 outpatient
visits, 29,135 echocardiograms, 1,366 cardiac MRIs, and 646 cardiac CT scans. Over 3 years (2020-2022),
HC faculty have participated in 54 prospective multicenter research studies, directed 18 imaging core labs, and
been PIs of data coordinating centers for 14 multicenter studies. The HC employs 6 data managers, 36
research assistants and coordinators, and 9 statisticians (4 PhD, 5 MS). Within the PHN, BCH cardiologists
have been PI/MPI of 10 trials and cohort studies and directed 10 imaging core labs. BCH recruitment has been
in the top quartile of participating centers for 9 of 14 PHN studies that actively enrolled participants in the
current grant period, and in the top half for 13 of 14 studies. We have successfully recruited subjects on nights
and weekends via a call schedule, and, with a large, world-class adult congenital program, can recruit and
retain participants across the lifespan. BCH has state-of-the-art administrative and scientific capabilities that
can expand the scientific productivity of the PHN. These include a model research pharmacy, rich experience
in FDA-regulated studies, and world-class data science and data integration across multiple registries and
databases that include study outcomes and covariates. Our renowned biomedical informatics program
encompasses medical decision making, diagnosis, therapeutic selection, care redesign, clinical trials design,
cardiovascular machine learning, and artificial intelligence. BCH remains committed to recruiting patients of
diverse gender, race, and ethnicity from our large population with congenital heart disease (CHD), of whom
31% with reported race and ethnicity identify as minority. The proposed research protocol concept, a stepped-
wedge randomized trial of developmental care that leverages our strength in cardiac neurodevelopment, has
the potential to improve outcomes and advance equity, with likely greatest benefit in marginalized populations.
BCH is further committed to equity, diversity, and inclusion (EDI) through 1) academic scholarship in equitable
healthcare delivery, access, and outcomes; 2) leadership development for early-to-mid-career faculty in
minority groups; and 3) an EDI research review committee, created in collaboration with the BCH IRB, to
ensure that research is conducted using current rigorous health equity research methodologies. In summary,
BCH has exemplary credentials to be a PHN Clinical Research Center and has unwavering dedication to the
success of the PHN’s ongoing and future studies. In the next PHN cycle, BCH will contribute to innovative
research through the scientific expertise of its investigators, success in multi-disciplinary collaboration,
commitment to eliminating child health disparities in CHD, extensive administrative resources, and personnel
and processes with a proven track record for data integration across multiple registries and databases.

Public health relevance
NARRATIVE Congenital heart disease affects ~1% of live births and is the leading cause of mortality from birth defects; acquired heart disease affects thousands more each year. The Pediatric Heart Network is a multicenter research enterprise that has conducted 23 multicenter research studies including 12 clinical trials; 7 studies are currently recruiting participants. Boston Children’s Hospital has participated in the PHN since its inception in 2001 and here presents exemplary credentials to be a PHN Clinical Research Center in the next grant cycle.